The Role of T cells in children with anti-NMDA Receptor Encephalitis

PROJECT SUMMARY/ABSTRACT
Autoimmune encephalitis is a disease in which inflammation occurs in the brain and can cause high morbidity
and mortality. Anti-NMDA receptor encephalitis (NMDARE) is the most common cause of encephalitis and
occurs in children and adults. Those who survive NMDARE develop long-term neuropsychological sequelae,
including developmental problems in children. NMDARE treatments target antibodies and B-cells but 30% do
not respond to these treatments and require additional T-cell targeting therapies which have increased
toxicities and side effects. A lack of a prognostic biomarker is a major gap in the treatment of NMDARE.
Having a biomarker at the time of diagnosis to guide treatment optimal treatment in NMDARE can result in
improved outcomes. This five-year career development plan proposes using advanced immunological assays
including high-dimensional flow cytometry and single cell RNAsequencing (scRNAseq) to identify the role of T
cells in NMDARE, focusing on T helper 17 cells (Th17), a subset of CD4+ T cells that is pathogenic in other
autoimmune diseases. The hypothesis is that severe NMDARE is marked by elevated Th17 cells (identified
through blood and CSF cytokines, flow cytometry for immune cell profiling, and transcriptomics for identifying
functional elements of the immune cell’s genome) and Th17 cells could be a prognostic biomarker. The aims of
this NMDARE study is to 1) characterize how timing of T cell treatments affect outcomes in a retrospective
cohort of 19 sites and 362 children with NMDARE, 2) assess blood and CSF Th17 cells and related cytokines
using flow cytometry and electrochemiluminescence immunoassays respectively, and 3) use scRNAseq to
identify NMDA receptor specific T cells and to assess if intracellular pathways are different in Th17 cells from
NMDARE compared to controls. This proposed work supports the mission of the National Institute of
Neurological Disorders and Stroke in increasing knowledge about how the neuroinflammation affects the brain
and to use that knowledge to reduce the disease burden in NMDARE but also other neuroinflammatory
conditions. The candidate is committed to a career in the investigation of neuroinflammatory diseases to
understand the pathogenic immune pathways, and to improve treatments, by identifying optimal treatment
strategies by biomarkers and novel therapeutic targets. The candidate will train in performing laboratory
techniques such as high-dimensional flow cytometry and scRNAseq, and advanced statistical methods. This
training would equip the candidate to be a unique pediatric translational neuroimmunology clinician-scientist.
Overall this project proposes a novel translational approach to understanding NMDARE. While NMDARE is
rare, the candidate will leverage CONNECT, a multi-center prospective cohort to carry out this study, and the
results of this study could apply to other neuroinflammatory diseases such as multiple sclerosis to improve
patient outcomes, including neurodevelopmental outcomes in children.

Public health relevance
PROJECT NARRATIVE Autoimmune encephalitis (AE) occurs when the immune system attacks the brain, and can cause long-term neurological deficits. Immune treatments work for some people with AE but not for others, and sometimes it takes time to identify the appropriate treatment for AE. This work proposes to identify features to guide treatment in AE to improve outcomes, and also identify novel therapeutic targets that could help people with other neuroinflammatory diseases including multiple sclerosis.